North Texas ADRC - Clinical Core

The Clinical Core of the North Texas ADRC will facilitate innovative research to support the theme of
examining the roles and mechanisms of hypertension and other cardiometabolic factors in the early
phases of AD/ADRD, developing innovative biomarkers for early detection, and identifying related
therapeutic targets. The Clinical Core focuses on including cutting edge approaches and engaging
individuals from diverse backgrounds identified through our community-based and clinic-based recruitment
organized by the Outreach, Recruitment and Engagement (ORE) Core. Through interaction with the Biomarker
and Imaging Core, we obtain their “ATN” classification and leverage the participant tracking and data
infrastructure built by our Data Management, Informatics, and Statistical (DMIS) Core to manage recruitment,
retention, study workflows, and uploads for National data sharing. Because ADRD in many cases has multiple
coincident pathologies, it is critical to define phenotypic and genotypic parameters that aid in differential
diagnosis, determination of risk factors, prediction of course of illness to identify relevant underlying
neuropathology so that mechanism-based therapies can be developed and used efficiently. Our access to
sociodemographically diverse populations will maximize our collaborative team’s ability to recruit and follow
groups consistent with the ADRC research theme. The Clinical Core aims to recruit and retain a diverse cohort
of well-characterized individuals enriched for high cardiometabolic risk and for the pre- and early symptomatic
stages of AD/ADRD; Coordinate with other NT-ADRC cores to facilitate data and specimen sharing; facilitate
investigator-initiated and externally sponsored research; and provide training and educational opportunities. It
will serve as a regional hub for ADRD research and will be a resource for investigators and ongoing studies
that require well-characterized clinical samples, biospecimens, and bioinformation. In conjunction with the
other ADRC components, the Clinical Core will bring together North Texas investigators and provide logistical
support and expert specialty consultation and collaboration for investigator-initiated and national multi-site
projects to enhance multidisciplinary and translational ADRD research and education.